A Digital Mental Health Intervention for Pregnant People with a History of Neglect: Bridging Gaps in Mental Health Care

PROJECT SUMMARY
Childhood neglect, which constitutes 76% of confirmed child maltreatment cases, has lifelong repercussions.
These include increased vulnerability to stress, mental health challenges, and difficulties in forming and
maintaining relationships. Pregnancy, a profoundly sensitive developmental stage, amplifies the consequences
of childhood neglect due to increased physical and emotional demands. In addition, expectant individuals with a
history of neglect can have elevated mental health issues and health-related complications during this period.
These challenges may result in increased risk for perpetuating the cycle of neglect from one generation to the
next. Furthermore, acknowledging historical and systemic factors impacting childhood neglect among
marginalized communities is essential for effective interventions, as these factors have led to distrust in
healthcare systems, impeding access to care. Digital mental health interventions (DMHI) offer a potential
solution, as they provide flexibility, privacy, and reduced stigma, ensuring accessibility and tailored support for
individuals. Yet, no current intervention targets the prevention of the intergenerational neglect during the perinatal
period via a digital format. The proposed research seeks to adapt and assess the initial efficacy of a DMHI
tailored for pregnant people with a history of neglect, with the overarching goal of preventing the intergenerational
transmission of neglect. I will leverage an existing DMHI, Mamma Mia, which is a effective DMHI designed to
prevent perinatal depression. I will adapt, enrich, and tailor the DMHI Mamma Mia content to suit the unique
needs of the target population (i.e., pregnant people with a history of neglect in childhood) (Aim 1). Aim 2 will be
an open trial (N=20) to assess the DMHIs feasibility, usability, and acceptability utilizing quantitative and
qualitative data. Aim 3 will be a randomized pilot study (N=100) to compare an intervention group (n=50) and a
care as usual group (n=50) to evaluate the DMHI's preliminary impact on pre- to-post-intervention knowledge of
the impact of early adversity, perceptions on parenting, and depression symptoms. The long-term goal is to
leverage the insights gained from this research to secure larger-scale funding (R01) for a comprehensive study
or further refinements to the intervention. Subsequent phases will involve larger cohorts, follow-up assessments,
and the potential exploration of biological outcomes. This research addresses a critical gap in child maltreatment
prevention by focusing on the often understudied, yet highly prevalent issue of neglect, offering hope for breaking
the cycle of maltreatment across generations. My background in perinatal health, child development, early
adversity, and evidence-based interventions set the foundation for my training goals. I will extend this knowledge
to understand how neglect affects individuals during the perinatal period and the intergenerational transmission
of neglect (Training goal #1), receive training in DMHIs, with a focus on development, clinical trial methodology,
and applying these skills to perinatal interventions (Training goal #2), develop expertise in community
engagement and culturally-sensitive research (Training goal #3), and training around professional development
to develop skills in transitioning to an assistant (Training goal #4).

Public health relevance
PROJECT NARRATIVE Childhood neglect, which comprises the majority of child maltreatment cases, has profound lifelong effects, particularly during pregnancy due to increased stress and mental health challenges during this critical period. The goal of this K99/R00 is to adapt and assess the efficacy of a tailored digital mental health intervention for pregnant people with a history of neglect, with the goal of preventing the intergenerational transmission of neglect. This digital intervention aims to promote equity in mental health services, ensuring that all families have access to effective, tailored interventions, fostering a healthier nation for generations.